FASEB SRC: Structure and Function of Small GTPases

Summary
Rational drug design for cancer requires a thorough understanding of signaling networks in order to reveal nodes
that can be targeted. Small GTPases are central components of numerous signaling pathway, including many
that drive oncogenesis and metastasis. Small GTPases are binary switches that are interconverted from the
GDP-bound off to the GTP-bound on state by receptors and regulatory molecules and, when in the on state,
drive signaling through various effector molecules. The superfamily of small GTPases number more than 160
gene products and can be divided into five families: RAS, RHO, RAB, ARF and RAN proteins. RAS proteins
were the first small GTPases identified and remain the best studied. RAS genes are the oncogenes more
frequently mutated in cancer than any other, which accounts for the intense interest in understanding and
targeting these GTPases. The FASEB Summer Research Conference on Small GTPases was founded in 1991
and has been held every two years since. The conference has consistently attracted the leaders in the field and
has played a large role in driving the field forward and promoting collaborations that have expedited discoveries
that have been translated into drug discovery. The conference has also served as a platform for encouraging
young investigators to enter the field. This application seeks partial funding for the 30th Anniversary Meeting
of the FASEB SRC on the Structure and Function of Small GTPases. The meeting will feature a keynote lecture
by Channing Der, one of the co-founders of the meeting who remains a driving force in the field. Also featured
will be 28 plenary talks. Fifty percent of the invited speakers are new to the conference and are intended to bring
fresh ideas and technologies. Twenty short talks will be selected from submitted abstracts and delivered by
young scientists. All attendees will present posters. Opportunities for informal discussions and for networking
will abound over the 5-day meeting that will include unscheduled time in the afternoons as well as a Meet-the-
Expert lunch and a Career Development breakfast. Forty-three percent of invited speakers are woman. A
concerted effort is planned to recruit trainees who are members of underrepresented groups. Ten
travel/registration awards will be made to trainees with preference given to underrepresented minorities.

Public health relevance
Narrative Small GTPases are molecular switches that control numerous signaling networks involved in tumor growth and are therefore of great interest to cancer biologists seeking to develop novel therapies. We propose the continuation of a highly successful scientific conference that has been held every two years since 1991 and has served as a critical platform to advance the scientific field.